Genome Technologies Coordinating Center

PROJECT SUMMARY
The Genome Technology portfolio at NHGRI encompasses a substantial diversity of scientific approaches and
objectives, from instrumentation development to high-throughput application of technologies to characterizing
the genomic basis for phenotypic traits. These research efforts have produced significant insight into biology and
disease, and yet there are many opportunities to accelerate innovation, development, and early dissemination
of genomic technologies. The goal of the Genome Technology Coordinating Center (GTCC) is to maximize these
opportunities by liaising grantees and NHGRI Program Staff, managing research funds, and developing
educational resources to support and tout the excellence of the Genome Technology program. We propose the
following aims to meet these goals: 1) Facilitate collaborations across the Genome Technology Program and
promote standards that aid in achieving Program goals. We will host and support Annual meetings for the
Genome Technology and CEGS programs. We will also develop Working Groups among grantees to promote
collaboration-building and the development of metrics and standards for genomic technologies. We will use these
Working Groups to identify gaps in the field that will provide the foundation for solicitation of Opportunity Funds.
2) Establish and manage an Opportunity Funds program to support initial development of promising new
technologies and ideas. These Opportunity Funds will be distributed as pilot projects (early stage or proof-of-
principle studies) and development projects (comparatively advanced studies with supportive preliminary data)
in years 2-4. Peer review will be conducted by an External Review Panel of experts in genomic technology. 3)
Implement community outreach activities to encourage awareness of Genome Technology Program successes
and facilitate access by the scientific community. We will develop and manage an Education and Outreach
Working Group composed of grantees and educational experts to identify and prioritize areas of development
for educational materials, and host and advertise a website to distribute those materials. A targeted effort will be
made to expose underrepresented and underserved populations in science to the advances and importance of
the Genome Technology Program. Informational resources related to technology transfer and intellectual
property will be developed for grantees. The Jackson Laboratory (JAX) is uniquely qualified to serve as the
GTCC for the Genome Technology Program. The Laboratory has over ninety years of history in supporting
mammalian genetics research including through the provision of widely used information resources (e.g. Mouse
Genome Informatics) and educational programs including the Annual Short Course on Experimental Models of
Human Cancer (29 years), and the McKusick Short Course on Human and Mammalian Genetics and Genomics
(nearly 60 years). The Jackson Laboratory for Genomic Medicine was established in 2012 to apply the Lab’s
expertise in genomics and technology development toward improvements in genome-based medicine.

Public health relevance
PROJECT NARRATIVE The NHGRI Genome Technology (GT) Program supports innovation, development, and early dissemination of genomic technologies. The goal of the Genome Technology Coordinating Center (GTCC) is to accelerate technology development and progress in the field of genomics through its support of GT grantees. To achieve this, the GTCC will pursue three over-arching objectives: 1) coordinating interactions among NHGRI Genome Technology grantees to enhance communication and encourage setting and meeting of performance objectives, 2) managing an Opportunity Funds program to promote early-stage development of innovative technologies, and 3) facilitating outreach by grantees to share results of their efforts with the scientific community.